Digital Monitoring of Emotion Regulation and Suicidal Ideation among Individuals at Clinical High Risk for Psychosis

PROJECT SUMMARY
Individuals clinical high risk for psychosis (CHR-P) are at increased risk for suicide with approximately 66%
reporting suicidal ideation and up to 30% reporting suicidal behavior. Despite these high rates, very little is
known about the mechanisms that contribute to suicidal thoughts in this population. The proposed study
addresses this gap by examining emotion regulation as a mechanism for suicidal ideation using the Extended
Process Model as a guiding framework. According to this model, emotion regulation is a dynamic process that
involves 1) the identification of the need to regulate, 2) the selection of an emotion regulation strategy, 3) the
implementation of that strategy, and 4) ongoing monitoring dynamics to determine whether to maintain, switch,
or stop strategies. Our preliminary data using ecological momentary assessment (EMA) suggests that
individuals with psychosis exhibit abnormalities across all of these stages. Additionally, we have found that
identification, selection, and implementation stage abnormalities are associated with suicidal ideation in real
time. More specifically, suicidal ideation is associated with a higher threshold for deciding to regulate,
suggesting that this population may be regulating too late. This finding has critical implications, as regulating
too late may subsequently influence strategy selection and effectiveness, resulting in emotional cascades that
often precede suicidal ideation. This may be particularly relevant for individuals at CHR-P, given the
established finding that they have difficulty identifying and recognizing their emotions—critical information that
is needed to determine when to regulate. Thus, innovative time-sensitive approaches are needed to detect and
assist individuals at CHR-P with identifying when to regulate. To address this gap, the current project will
combine EMA, wearable sensors, and smartphone-based technology to study emotion regulation as a
mechanism for suicidal ideation in CHR-P using the Extended Process Model as a guiding framework. We will
recruit 40 individuals at CHR-P with suicidal ideation/behavior, 40 clinical controls with suicidal ideation/
behavior, and 40 non-clinical controls to complete two research visits (baseline and 1mo follow up) and 28
days of intensive ambulatory assessments (EMA, wearables, smartphone sensing). This data will be used to
complete the following aims: 1) Estimate the effect sizes for unique and trans-diagnostic emotion regulation
stages predicting time-lagged suicidal ideation in CHR-P; 2) Establish the validity of using wearable and
smartphone sensors to objectively detect emotion regulation stages in real time. Findings from this study will
inform future grants designed to develop/test prospective algorithms for predicting suicidal ideation and
develop/test a just-in-time intervention for reducing suicide risk among individuals at CHR-P.

Public health relevance
PROJECT NARRATIVE Individuals at clinical high risk for psychosis (CHR-P) are at increased risk for suicide. The proposed study will combine ecological momentary assessment, wearables, and smartphone-based sensors to examine specific emotion regulation abnormalities that lead to suicidal ideation among individuals at CHR-P compared to clinical and non-clinical controls. Identifying the specific emotion regulation abnormalities that lead to suicidal ideation and novel methods to detect these abnormalities can inform the development of a targeted, scalable suicide intervention that can be delivered to those who need it most, when they need it most.